Activation of the Oxytocin System by Neuropeptide S to Generate Anxiolysis and Curb Alcohol Drinking

Project Summary
Alcohol dependence (AD) is characterized by exacerbated brain stress signaling that drives an anxious state in
alcohol withdrawal and contributes to the intensity of alcohol drinking, which can contribute to alcohol use
disorder (AUD). AUD is a global public health issue for which more effective treatments are urgently needed.
Preclinical data suggest that Neuropeptide S (NPS) treatment induces an anxiolytic effect that can counter the
enhanced anxiety observed in rodent models of AUD. Interestingly, it has been recently demonstrated that NPS
treatment activates hypothalamic oxytocin neurons (oxytocin system activation in alcohol dependence is the
focus of the parent R00 award). We hypothesize that 1. Neuropeptide S treatment will produce a therapeutic
action of anxiolysis in AD, thereby lessening the motivation to consume alcohol and that 2. NPS can produce
anxiolytic and anti-drinking effects through activation of oxytocin neurons within the hypothalamus.
While the NPS system is listed as an important target in AUD by the National Institutes of Alcohol Abuse and
Alcoholism, we are not aware of any study that has reported the effect of NPS on alcohol drinking in alcohol
dependence. Tests of NPS’s effects on anxiety and alcohol drinking in genetic lines selected for high drinking
support our hypothesis that NPS produces an anxiolytic and anti-drinking effect, however, we are eager to
conduct the experiments which can systematically demonstrate a role for NPS in alcohol dependence
contrasted with non-dependence. Further, we seek to test our hypothesis that NPS can produce these putative
therapeutic actions via activation of the brain oxytocin system. To test our hypotheses, we propose to first test
the effect of NPS in an acute model of alcohol-withdrawal-induced anxiety, while monitoring oxytocin release in
the central amygdala (a terminal region for hypothalamic oxytocin projection neurons, and a major focus of the
parent grant). Next, we will test the effect of NPS on the motivation to self-administer alcohol in the chronic-
intermittent exposure to vapor model of alcohol dependence, while also determining whether optogenetic
inhibition of hypothalamic oxytocin neurons (see parent R00 award) can prevent this NPS action.
The proposed project will serve as a training opportunity for John Marendes Jr. Our Research Plan is
designed to allow John to work within the scope of the parent grant, undertaking his graduate training with close
mentorship, but at the same time, to begin developing an independent research niche. This critical aspect of the
proposal will greatly benefit John in preparing for an independent research career in the future.
With this behavioral neuropharmacology approach, John’s completion of the proposed project is expected to
reveal new information about the role of NPS and oxytocin signaling in alcohol dependence. It is anticipated that
this data will open a new avenue for research into the neurobiology of alcohol dependence, and thereby have a
sustained impact on alcohol research in terms of both basic neuroscience and translational medicine.

Public health relevance
Project Narrative Alcohol dependence is characterized by exacerbated brain stress signaling that drives an anxious state in alcohol withdrawal and that contributes to the persistence of alcohol use disorder. The present proposal seeks to better define a role for Neuropeptide S in the etiology of alcohol dependence by testing the ability of NPS to activate the brain oxytocin system and thereby produce an anxiolytic effect in a rat model of alcohol-withdrawal induced anxiety. Further we seek to test the ability of Neuropeptide S, through activation of the oxytocin system, to produce an “anti-stress” profile of action and thereby curb the motivation to consume alcohol in a rat model of alcohol dependence.